Chemical Analysis Facility Core

The Chemical Analysis Facility Core (CAF) is a state of the art mass spectrometric based analytical support service. It provides support to the Center Investigators by performing small molecule analysis including methods development, training and sample analysis. The CAF uses;inductively coupled plasma mass spectrometry (ICPMS) for the bulk of its elemental analysis, gas chromatography mass spectrometry (GC/MS) for its semi-volatile and volatile molecular analytes and high performance liquid chromatography mass spectrometry (HPLC/MS) for its nonvolatile and polar chemical analysis. The CAF has dedicated personnel, space, instrumentation, and software to support the Center investigators.